T-cell depletion and maintenance of the HIV-1 latent reservoir in distinct tissue compartments

The primary challenge in curing HIV-1 is the persistence of a latent viral reservoir (LVR) in resting CD4+ (rCD4)
T cells that harbor stably integrated latent HIV. Examining changes in the LVR composition is incredibly difficult
due to the long half-life. Recent data show that clonal expansion of latently infected rCD4 T cells through a
combination of antigenic stimulation, homeostatic proliferation, and integration site promotor disruption are
major contributors to LVR maintenance. It is unclear which tissue source is the primary driver of LVR
maintenance, as well as what level of contribution each of these three potential mechanisms driving proliferation
may play in that process. Solid organ transplantation in people living with HIV and the associated different T
cell induction strategies prescribed for prophylactic allograft rejection treatment provide a unique opportunity to
examine how the LVR rebounds after a large proportion of the T cell repertoire is destroyed. The HOPE in
Action HIV+ kidney organ transplantation trial provides access to >120 matched flash frozen lymph nodes (LN),
renal allograft tissue, and longitudinally collected peripheral blood mononuclear cells (PBMC) from PLWH. We
hypothesize that the LVR is primarily maintained through antigen stimulation of latently infected cells in micro
foci within lymph nodes, which subsequently migrate into the circulation and other tissues in the body, thereby
reestablishing the LVR post-T cell depletion therapy.
Aim 1: Examine long-term LVR dynamics post-renal transplantation and its association with clinical outcomes.
We will measure the HIV LVR annually for up to 10 years using the intact proviral DNA assay (IPDA), which
distinguishes fully intact HIV from defective, deleted, and hypermutated proviral DNA, in individuals receiving
transplant-related immunosuppressive drugs that are of interest to HIV cure strategies. Aim 2: Develop a tissue
specific atlas of the LVR in LN, blood, and organ tissue (kidney) pre-transplantation, and examine reseeding of
the circulating, LN, and kidney allograft LVR post T cell induction. We will assemble a multi-modal atlas of HIV+
LN by integrating the CODEX multiplexed immunofluorescence (mIF) platform to phenotype lymphoid cells and
laser capture microdissection (LCM) and site-directed next-generation sequencing of the proviruses in cells
isolated from distinct LN zones. HIV SMRTcap, a novel HIV-specific single molecule sequencing assay will
provide simultaneous resolution of proviral sequences and matched integration sites, to evaluate clonality and
intactness of latent provirus within the LN, PBMC and kidney. Aim 3: Determine the relative contribution of
homeostatic proliferation, antigenic stimulation, and integration site promoter disruption on LVR maintenance
and re-establishment post-transplant.
These proposed studies will enable us to characterize the longitudinal LVR spatially, genetically, and
phenotypically in multiple compartments. This project will provide critical information on feasibility and
mechanisms of potential HIV cure strategies by modeling re-seeding of viral populations in kidney allograft and
lymphoid tissues and determining driving mechanisms of clonal proliferation.

Public health relevance
Project Narrative The challenge in curing HIV-1 is the persistence of a latent viral reservoir (LVR) that primarily resides in resting CD4+ (rCD4) T cells despite effective antiretroviral therapy (ART). The proposed study will evaluate the LVR spatially, genetically, phenotypically, and immunologically in multiple compartments among people living with HIV, undergoing renal transplantation, and receiving different T cell induction strategies prescribed for prophylactic allograft rejection. These studies will provide critical information on feasibility and mechanisms of potential HIV cure strategies by modeling re-seeding of viral populations in allograft and lymphoid tissues and determining driving mechanisms of clonal proliferation.